SCG PARENT CONTRACT HHSN26120140011I - Task Order No.67TITLE: "Strategic Planning and Communications Support for the Healthcare Delivery Research Program (Program Support)." Period of Performance: M

Strategic Planning and Communications Support for the Healthcare Delivery Research Program (Program Support)